Evaluating the impact of TP53 mutation on the epigenetic therapy viral mimicry response in the non- small cell lung cancer tumor

Non-small cell lung cancer (NSCLC) is the leading cause of cancer-related deaths in the United States. FDA approval
of immunotherapy represents a major therapeutic advance, but long-term survival remains limited, and combinatorial
approaches that maximize antitumor immune responses are an urgent clinical priority.
Low-dose DNA methyltransferase inhibitor (DNMTi) reverses cancer-associated hypermethylation to impart durable
genome-wide expression changes in NSCLC and other cancers. This includes activation of cellular antiviral signaling
via viral mimicry, wherein derepression of endogenous retroviral (ERV) sequences forms cytosolic double-stranded
RNA that triggers an interferon-dependent transcriptional program. Viral mimicry is critically dependent on transcriptional
alterations in mitochondrial respiration and ox-phos pathways, generating reactive oxygen species that damage and
fragment mitochondrial DNA, which leaks into to the cytosol and activates Stimulator of Interferon Genes (STING).
Notably, both STING activation and DNMTi viral mimicry have been linked to modulation of the tumor microenvironment
(TME) towards an immune-favorable phenotype, priming for enhanced response to immune checkpoint inhibitors (ICI).
The tumor suppressor TP53 is mutated in ~50% of NSCLC. Mutations are functionally categorized into DNA contact
mutants, where DNA interaction is impacted, and structural mutants, where protein folding is perturbed at a local or
global level. TP53 mutation is associated with a chronically inflamed immunosuppressive tumor microenvironment that
correlates to non-durable ICI responses and poor survival outcomes. Our novel preliminary data indicate that TP53
mutational category may fundamentally influence cellular response to DNMTi across multiple inputs, including activation
of ERV transcription, orchestration of the mitochondrial DNA damage response, and modulation of STING signaling.
Our central hypothesis is that p53 plays a critical role in shaping DNMTi viral mimicry, and that the resulting TME
immunophenotype is differentially modulated across the spectrum of TP53 mutations. We propose the following
strategies to test this hypothesis: 1) employing a clinically relevant, technologically advanced recapitulation of the TME
by co-culturing TP53-mutant patient-derived organoids with their corresponding cancer-associated fibroblasts, allowing
us to model bidirectional interactions governing TME immunomodulation using single cell RNA-seq and functional
cellular analyses; 2) interrogating multiple next-gen sequencing modalities to integrate p53 chromatin binding, ERV
sequence annotation, and gene expression data to evaluate impact of TP53 mutation on DNMTi-induced transcriptional
profiles; and 3) examining molecular mechanisms contributing to viral mimicry, with focus on the mitochondrial DNA
damage response. The proposed research aims to identify opportunities for strategic therapeutic personalization by
combining ICI with epigenetic drugs, addressing a major clinical need of improving treatment outcomes in NSCLC.

Public health relevance
Immunotherapy represents an important advance in lung cancer treatment, but responses are often short-lived, including in the ~50% of lung cancers with TP53 mutations. Epigenetic drugs activate tumor cell antiviral signaling, priming for immunotherapy responses. This project will investigate how TP53 mutations shape the immune response to epigenetic therapy in tumor cells and the surrounding microenvironment, offering insights into the therapeutic potential of this combination approach in lung cancer.